Harnessing CD4 T follicular helper 1 cells for HIV vaccine efficacy

Project Summary
This proposal aims to enhance HIV prevention with a vaccine approach that promotes durable immunity. The
studies center on CD4 T helper cells within lymph nodes, crucial for humoral and cytolytic memory. Our objective
is to induce robust CD4 T follicular helper (Tfh) cells as they are essential for vigorous B cell activity within
germinal centers (GC). We aim to promote Tfh cells that facilitate differentiation of GC B cells to plasma cells,
essential for persistent antibodies, by fine-tuning the innate inflammatory response with adjuvanted
vector/protein immunization in rhesus macaques.
Our published studies in macaques have shown that stimulating specific Tfh1 cell subset promotes HIV Envelope
(Env) antibodies with enhanced persistence and avidity (JVI, 2020; eLife, 2023). In this proposal, we will examine
whether a vaccine platform tailored to promote Tfh1 cell differentiation during both the prime and boost, in
combination with trimeric Env antigens, enhances Env antibody durability leading to increased protective efficacy
20 weeks after final immunization. Our approach uses adjuvanted Clade A Env DNA (weeks 0, 4, and 8) to prime
Tfh1 cells. To intensify the Tfh1 response, a second group will receive an adjuvanted mRNA prime. Groups primed
with unadjuvanted DNA and mRNA will assess significance of Tfh1 priming in sustaining humoral immunity. All
four groups will receive Clade A Env protein boosts formulated in ALFQ (weeks 16 and 24) to reinforce Tfh1 cell
memory and drive sustained GC responses.
In Aim 1, we will perform detailed immune analyses across DNA and mRNA platforms to uncover mechanisms
of effective Tfh help in humoral immunity against HIV. In Aim 2, we will evaluate the long-term effectiveness by
measuring protection at week 44, 20 weeks post final boost. In addition to comprehensive cellular immunology
analysis of blood and lymph nodes and serological assessments in blood and mucosal sites, animals will be
monitored for potential vaccine-related adverse events. Our comprehensive and multifaceted approach, pairing
adjuvanted nucleic acid priming with a protein boost and directly comparing mRNA and DNA priming modalities
for immunogenicity and protection, aims to enhance longevity and affinity of HIV-Env antibodies. This innovative
strategy targets Tfh cells in a way not previously attempted, offering the potential for insights in HIV vaccine
development. These collaborative studies are supported by teams from the University of Pittsburgh, Emory
University, and Louisiana State University. These teams bring a wealth of expertise in adjuvanted vector design,
Tfh biology, humoral immunity, as well as bioinformatics and biostatistics. In summary, our studies, centered
around leveraging molecular adjuvants to enhance the Tfh1 cell response, have the potential to innovate HIV
vaccine design. Our long-term objectives are to integrate strategies to induce Tfh cells, optimized for B cell helper
function, into potent broadly neutralizing antibody-inducing platforms to improve HIV vaccine efficacy.

Public health relevance
Project Narrative In this proposal we will utilize innovative molecular adjuvants to augment CD4 helper T cell responses with the primary objective of establishing sustained immunological memory against HIV.